Long non-coding RNA signatures to distinguish relapsing-remitting multiple sclerosis from primary progressive and secondary progressive multiple sclerosis

PROJECT SUMMARY
Diagnosis and monitoring of multiple sclerosis (MS) rests on clinical symptoms and examinations as outlined
in the revised McDonald criteria. These criteria are supported by appropriate magnetic resonance imaging (MRI)
findings or other laboratory tests such as detection of oligoclonal bands in cerebrospinal fluid and evoked
potential testing.(1-7) Approximately 10,000-15,000 new diagnoses of MS are made in the United States each
year.(8) MS is classified into phenotypes depending on the patterns of demyelination of the central nervous
system [CNS], inflammation and disability progression.(9) The vast majority of patients, approximately 80%-
90%, will develop a relapsing-remitting course of disease (RRMS) where symptoms develop over the course of
a few days or a few months and then greatly improve or remit entirely. Up to 50% of patients with RRMS advance
to secondary progressive MS (SPMS) within 10-15 years of the initial relapsing-remitting course and up to 90%
of RRMS patients will transition to SPMS within 20-25 years.(10, 11) In contrast to the variations in RRMS
symptoms, SPMS patients typically experience a steady progression of disease with or without relapses. Should
relapses occur in SPMS, they typically do not fully remit. Early treatment with disease-modifying therapies has
been shown to slow or prevent the transition of RRMS to SPMS. In addition to RRMS and SPMS, approximately
15% of patients will develop a primary progressive course of disease (PPMS) where disability progression
continuously accumulates without evidence of remission. Disability in MS accrues predominantly in the
progressive forms of the disease, creating a substantial health-care burden at individual, family and community
levels.(10)
There are more than a dozen approved therapies for RRMS.(12, 13) In contrast, only one treatment is
approved to treat PPMS (ocrelizumab). Furthermore, with the exception of siponimod, approved in 2019 and
investigated in the largest randomized clinical trial to date in SPMS, clinical data collected in SPMS patients
treated with approved RRMS disease-modifying therapies remains an area of active investigation and
debate.(10) Most clinicians commonly prescribe ocrelizumab, rituximab, or siponimod based on emerging
evidence showing decreased disability.(14-16) The ability to quickly and accurately distinguish each type of MS
in patients is important, as each MS subtype requires specific approaches to ensure effective treatments are
prescribed and optimal clinical outcomes are achieved.(9, 17) Mischaracterization of MS can produce a
significant cost burden on the healthcare system since certain approved therapies for RRMS lack evidence
showing efficacy slowing SPMS or PPMS.
Difficulties in identifying the correct MS phenotype can lead to patients receiving/remaining on therapies that
are ineffective resulting in unnecessary costs and potential for adverse effects. As new therapies are introduced,
especially those with potential neuroprotective effects for treatment progressive forms of MS, early classification
of disease phenotype may represent a window of opportunity for therapeutic intervention.(9, 10, 16, 17) The cost
of managing MS patients is rising and can exceed $50,000 per year. Identification of actionable biomarkers
would provide clinicians with additional information for the purposes of diagnosis, prognosis, clinical subtyping
and therapy selection.
The question of whether or not disease classifiers capable of providing clinically useful information could be
built based upon disease-specific expression levels of mRNAs in whole blood has been a subject of research for
greater than ten years. Many disease-specific gene expression signatures have been identified in the research
setting.
Long non-coding RNAs (lncRNA) are recently discovered regulatory RNA molecules that do not code for
proteins but influence a vast array of biological processes. In vertebrates, the number of lncRNA genes is thought
to greatly exceed the number of protein-coding genes. It is also thought that lncRNAs drive biologic complexity
observed in vertebrates compared to invertebrates. These lncRNAs also appear to show much greater cell-type
specific expression patterns than mRNAs. Humans also develop many more complex diseases than other
organisms. As such, our data presented in preliminary studies, support the notion that disease-associated
lncRNAs exhibit far greater differences in expression than disease-associated mRNAs. In this application, we
propose to explore the hypothesis that lncRNAs are better biomarkers of human disease than mRNAs. Here, we
will focus on RRMS, SPMS, PPMS, and disease controls as disease categories. We will identify and validate
differentially expressed lncRNAs found in each MS subtype that are capable of distinguishing among each
subtype versus healthy controls as well as disease controls.

Public health relevance
NARRATIVE Diagnosing multiple sclerosis and further classifying the disease into relapsing-remitting, primary progressive, or secondary progressive subtypes can be a difficult, long and costly process and misdiagnosis is not uncommon. As new therapeutics emerge that target specific subtypes of multiple sclerosis, new diagnostic tools capable of distinguishing among these subtypes could assist clinicians as they develop a treatment plan. Long non-coding RNAs (lncRNA) are a new class of regulatory RNA molecules that exhibit high degrees of cell-type specific expression. The hypothesis we will test in this application is that measurement of expression of disease-specific lncRNAs in primary progressive and secondary progressive multiple sclerosis will have greater utility to provide meaningful clinical information to health-care providers faced with this diagnostic dilemma than measurement of disease-specific mRNAs.